BIOLOGICAL MEDIATORS OF THE DISEASE WEIGHT LOSS RELATION AMONG OLDER PERSONS

The purpose of this agreement is to fund the drawing, transporting, processing and analysis of blood specimens from the Framingham Heart Study cohort in Examination Cycle 22 and the collection of bioelectric impedance data from members of the cohort in Examination Cycle 25.